Implementation Science and Equity: Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
Many advances in prevention and treatment of disease—that were funded by NIH and other agencies—
take decades to become adopted into clinical practice. The long-term goal of Implementation Science and
Equity is to develop a multidisciplinary, internationally recognized research COBRE focused on the theme
of implementation science, equity, and health. Given the novel nature of the COBRE, and the
multidisciplinary and multi-site nature of implementation research, a well-organized and efficient
Administrative Core is essential to the overall management of the COBRE. To support this effort, the
Administrative Core will tap resources in existing programs, centers, and institutional shared resources at
KUMC to support Project Leads’ research and development.
The Administrative Core will set the overall scientific direction of the Implementation Science and Equity
COBRE’s research, coordinate and integrate all of the COBRE’s activities with the goal of establishing an
infrastructure at KUMC to sustain these activities long-term beyond the scope of the current project. To
do so, the Core will pursue 5 specific aims.
Aim 1. Develop infrastructure to advance the field of health equity using the tools of
implementation science.
Aim 2. Develop and implement a mentoring and career development system including career
development plans, strong mentoring, institutional training and resources, and replacement of
Project Leads who achieve R01 or equivalent funding for their research.
Aim 3. Convene an Internal Advisory Committee (IAC) and External Advisory Committee (EAC) to
guide and evaluate the Implementation Science and Equity COBRE.
Aim 4. Administer and evaluate the Research Pilot Project Program.
Aim 5. Evaluate the success of Implementation Science and Equity in achieving mission-relevant
outcomes at the Project Lead and institutional level.
COBRE PI and Co-Director, Richter and Befort, have extensive experience in mentoring junior faculty;
administering large research trials, centers, and training Cores; working with rural and urban primary care and
safety net providers; and collaborating with practice-based research networks. The techniques and
approaches developed by Implementation Science and Equity COBRE faculty have strong potential for
sustained impact on the field of implementation science, and the health status of underserved Americans,
by developing methods to accelerate translation of research findings into practice.